Development of high parameter spatial transcriptomics and proteomics for the study of tumor microenvironments

Project Summary/Abstract
The technical and biologic expertise offered by Research Specialists provides a foundation of support that
expedites the growth of research programs, shared resources, and cancer centers. Especially important in
complex fields, such as the growing use of immunotherapeutics in personalized treatment of cancer, a
comprehensive understanding of biologic responses requires cutting-edge technology and expertise that would
be cost prohibitive to develop in individual laboratories. Monitoring immune responses in patients treated with
immunotherapies is vital to understanding the mechanisms involved in these treatments and for the rational
design of combinatorial clinical trials. This proposal demonstrates the need for support of the Research
Specialist in the continued development of critical services provided by the Human Immune Monitoring Shared
Resource (HIMSR), a University of Colorado Cancer Center (UCCC) Shared Resource at the University of
Colorado Anschutz Medical Campus. The Research Specialist collaborates with UCCC members to support
cancer-related investigator-initiated clinical trials with a full-service approach, from sample processing, to
optimization and implementation of high parameter correlative assays for liquid and tissue biopsies, to primary
data analyses. Continued support of the Research Specialist with this NCI R50 funding mechanism will allow
time for the implementation of new technologies for spatial proteomic and transcriptomic imaging for use in the
study of tumor microenvironments, development of novel computational approaches and improvements to
existing computational tools for primary image analyses, and continued advancement of existing imaging
technology with customized multiplex panels. Dr. Jordan's expertise and training in immunology and human
clinical studies is a vital component of the Unit Director's Cancer Center Support Grant, many research
programs of UCCC members, and to the completion of projects under the Head and Neck SPORE (NCI P50).
As evidenced by rapidly expanding publications and funding opportunities that stem from its advanced
techniques, the HIMSR has become an integral part of many research programs on campus and will be a vital
component of the future growth of immunotherapies at CUAMC.

Public health relevance
Project Narrative The Human Immune Monitoring Shared Resource (HIMSR) serves faculty and trainees at the University of Colorado Anschutz Medical Campus (CUAMC) and CU Cancer Center members across the front range campuses (National Jewish Health, CU Boulder, CSU, VA, and Children's Hospital). The goal of this proposal is to support the Research Specialist in further development of this shared resource, which aims to provide immunology expertise, technically advanced instruments, and assays for the interrogation of immune cells in cancer patients and tumor microenvironments. The productive collaborations formed by the Research Specialist and the expertise further developed by this proposal will contribute to a better understanding of the underlying mechanisms of cancer immune evasion, identify prognostic biological measures for responses to cancer treatment, and help develop rationale for future novel combinatorial treatments.